Resting-state Neural Networks in Awake Rodents

Project Summary/Abstract
The brain is a highly inter-connected network system, with distributed brain regions orchestrating to maintain
normal brain function and mediate complex behavior. It is becoming increasingly clear that altered brain network
properties underlie mental illness, but the neural substrates causing these large-scale network changes
remain unknown. A key hypothesis is the dysfunction of brain hub regions. Hubs are brain regions that have
high degrees of connections with the rest of the brain network. Because of their central roles, dysfunction of hub
nodes can change global integrative process, and has been hypothesized to be a direct cause of altered brain
network function and pathophysiology of brain disorders. However, directly testing this hypothesis in humans is
challenging, as selectively manipulating activity in a hub and dissecting its causal impact on brain networks is
difficult. We will bridge this critical gap using cutting-edge tools to manipulate the activity of a hub, and monitor
the impact of these manipulations on brain networks using resting state functional magnetic resonance imaging
(rsfMRI) and behavior in an awake rat model. In the current grant cycle we have established the rsfMRI approach
in awake rats, which allows us to reliably measure resting-state functional connectivity (RSFC) and characterize
brain network properties in rats. We have built on our awake rat rsfMRI approach by incorporating Designer
Receptors Exclusively Activated by Designer Drugs (DREADDs), optogenetics, electrophysiology and animal
behaviors. With these capacities, we can causally manipulate the activity in a hub brain region, and measure the
corresponding brain-wide network reconfigurations. Using optogenetics, we can manipulate neural activity on
the millisecond timescale, and using DREADDs, we can manipulate neural activity on the times scales of hours
to days. Finally, concurrent electrophysiology-fMRI will allow us to directly relate brain network and behavioral
changes to their neural basis. Our goal is to elucidate the causal impact of manipulating hub region activity on
brain network organization, function and behavior in awake rats using rsfMRI, DREADDs, optogenetics and
electrophysiology. In Aim 1, we will document changes in network properties including the network topological
organization and brain-wide RSFC dynamics induced by semi-acute suppression of a brain hub. With the cell-
type specificity of DREADDs, we will examine the role of the balance of excitation and inhibition in a hub in brain
network dynamics. To elucidate the relationship between activity of a network node and specific brain network
function, in Aim 2 we will dissect the functional role of each node in the default mode network and related
behaviors in rats. In Aim 3, we will further determine the impact of chronic suppression of a hub on long-term
network reorganization and behavior. Successful completion of the proposed research will elucidate the causal
relationship between short-term and long-term dysfunction of a hub and brain network reconfigurations, which
will help understand the neural substrates causing large-scale brain network changes.

Public health relevance
Project Narrative It has been hypothesized that dysfunction of brain hubs underlies brain network changes and neuro- pathophysiology of numerous brain disorders, but directly testing this hypothesis in humans is challenging. The proposed research will elucidate the causal impact of short-term and long-term suppression of a hub on brain network organization, function and behavior using an awake rodent model. Such knowledge will help reveal the neural substrates causing large-scale brain network changes, and provide insight into understanding the neuro- pathophysiology of brain disorders.